Evaluation of the Implementation of PrEP Provision for Ugandan Fisherfolk

PROJECT SUMMARY
In Ugandan fisherfolk communities, HIV prevalence is an order of magnitude higher than in the Ugandan
general population, and high HIV prevalence among fisherfolk helps to drive the general epidemic. In a prior
R21 study, we demonstrated that bringing HIV testing to fisherfolk communities, where healthcare facilities are
scarce, can identify a large number of high-risk HIV-negative fisherfolk. To have a significant impact on the HIV
epidemic among fisherfolk, a key next step in this research program would be to offer pre-exposure
prophylaxis (PrEP; a highly effective and safe daily pill containing tenofovir and emtricitabine to prevent HIV) to
high-risk HIV-negative fisherfolk following HIV testing. Although the 2016 Ugandan HIV prevention and
treatment guidelines recommend PrEP for HIV prevention in fisherfolk, there is currently no governmental
support for PrEP implementation in fisherfolk communities. Pilot data are urgently needed to demonstrate to
the Ugandan Ministry of Health that PrEP can be feasibly delivered to fisherfolk, in order to secure government
support for PrEP for fisherfolk. The Specific Aims are: (1) To conduct formative qualitative research to examine
barriers to and facilitators of PrEP uptake, and to obtain input on acceptable PrEP messaging and provision,
for fisherfolk communities on Lake Victoria, Uganda; and (2) To conduct a mixed-methods analysis comparing
the implementation of community-based vs. healthcare facility-based PrEP provision for fisherfolk communities
on Lake Victoria, Uganda. For both PrEP interventions, we will conduct monthly HIV testing and PrEP and
antiretroviral treatment provision events, using messages developed from the formative work to raise
awareness about PrEP. PrEP will be offered to 100 fisherfolk in two Lake Victoria landing sites during testing
events on specified days of the month: In one site, PrEP will be distributed in a nearby healthcare facility during
monthly events, and in the other site, PrEP will be distributed in a temporary community space. Among those
who are non-adherent (based on refill data), PrEP provision will be supplemented via PrEP delivery by
community health workers or at community PrEP pick-up points, based on strategies elicited in the formative
work. To evaluate implementation, we will conduct semi-structured interviews with healthcare providers and
fisherfolk who do and do not decide to initiate PrEP, and obtain medical records data to compare the
proportion of fisherfolk: identified as PrEP-eligible, who initiate PrEP, who adhere to PrEP (i.e., refills over 6
mos.), who seroconvert, and who discontinue PrEP, overall and by socio-demographic characteristics (e.g.,
gender). We will engage with Ugandan Ministry of Health policymakers throughout the research, to keep them
apprised of results and to determine directions for future policy around PrEP for fisherfolk. To realize the 90-
90-90 goals, it is critical to seek out the hardest to reach, most at-risk populations such as fisherfolk, who
reside and work in areas without easy access to healthcare.

Public health relevance
PROJECT NARRATIVE Among Ugandan fisherfolk, HIV prevalence is very high and is likely a driver of the general epidemic in the country. To have a significant impact on HIV among fisherfolk, it is essential to offer pre-exposure prophylaxis (PrEP) to high-risk HIV-negative fisherfolk in tandem with treating HIV-positive fisherfolk with antiretroviral therapy. We will evaluate the feasibility, acceptability, and preliminary effects of PrEP delivery interventions in two separate fisherfolk communities.